Development of an extracellular matrix-targeted theranostic radiopharmaceutical for metastatic lung cancer

PROJECT SUMMARY
Cancer is the second leading cause of death in the United States with metastatic cancers accounting for 70-90%
of all cancer fatalities. Lung cancer represents the most prevalent cancer type as well as the deadliest,
accounting for approximately 20% of all cancer-related deaths. Despite recent advances in novel molecularly
targeted therapeutic modalities, including antibody-drug conjugates, cell therapies, and immune checkpoint
inhibitors, many lung cancer patients fail to benefit from these treatments and urgently require new therapeutic
options, particularly for addressing disseminated metastatic disease. In contrast to targeting cell surface antigens
on tumor cells or other cell types, Matrisome Bio is developing targeted therapeutics specific for disease-related
components of the extracellular matrix (ECM), circumventing the need to reach tumor cells to facilitate drug
delivery and internalization. Some ECM targets present advantages over cellular targets due to the ECM’s high
abundance, its expression across various cancer types and stages of disease, including both early and advanced
tumors, and its slow turnover, which enables extended retention of ECM-targeted therapeutics at disease sites.
Research conducted prior to the founding of Matrisome Bio identified several proteins preferentially expressed
in the ECM of lung tumors and metastases. Matrisome Bio is developing molecularly targeted drugs based on a
suite of nanobodies that specifically target disease-associated ECM proteins that are highly expressed in lung
cancer and other cancer indications and minimally expressed in normal healthy organs. Published research from
Matrisome Bio’s founders demonstrates that ECM-specific nanobodies can effectively deliver various payloads
in mouse models of solid tumors and metastatic disease. The efforts outlined in this grant aim to build upon these
studies by developing a theranostic radiopharmaceutical targeted to an ECM component that we have identified,
which is expressed in over 90% of lung tumors and metastases, and which we believe holds the potential to
transform the treatment of advanced lung cancer. This Direct to Phase II SBIR application aims to (1) develop
refined binder molecules facilitating optimized biodistribution and tumor uptake behavior, characterize target
binding kinetics, and optimize preclinical-scale radiolabeling formulations; (2) characterize in vivo biodistribution
and clearance kinetics of select binders and determine tolerability in a dose escalation study in preclinical models
of lung cancer; and (3) evaluate preclinical efficacy, safety, and toxicity of lead binder molecules as well as
conduct a pre-IND meeting with FDA. This project aims to demonstrate the feasibility of developing and
optimizing ECM-targeting theranostic radiopharmaceuticals with characteristics suitable for effective use in the
diagnosis and treatment of advanced lung cancer in humans.

Public health relevance
PROJECT NARRATIVE Lung cancer is the leading cause of cancer-related deaths, with the majority of patients failing to respond adequately to currently available therapies and most often succumbing to metastatic disease within a few years of diagnosis. To address this major unmet clinical need, Matrisome Bio is developing innovative theranostic radiopharmaceuticals that target disease-specific components of the extracellular matrix surrounding tumor cells, and which are broadly expressed in primary tumors and metastases of lung cancer patients. This approach leverages a previously underexplored opportunity for targeted cancer therapies that can be applied for both imaging and therapy of advanced lung cancers to bring novel and efficacious treatments to patients.